Advancing the Next Generation: Mentoring and Pilot Papers

The Pilot/Mentoring Core for the renewal of the Brandeis/Harvard Center to Improve System Performance
of Substance Use Disorder Treatment will continue to advance the addiction health services research field
by encouraging, developing, and supporting investigators who are interested in conducting innovative research
related to delivery and payment of SUD treatment services. The activities of this new Core will focus on early
career investigators (doctoral students, post-doctoral fellows, early career faculty/researchers), but also will
benefit mid-career and senior researchers. Key elements will include mentoring programs, networking
activities, and educational opportunities, including a new Brandeis/Harvard Center of Excellence Systems
Performance Scholars Program. In addition, the Center will continue to support the development of important
new research by expanding awards to early career investigators to develop mentored “pilot” papers or small
studies that will advance the science in this area and serve as foundational work for their research agendas.
Additionally, the Center renewal will have an intentional focus on racial/ethnic diversity outreach in mentoring
to expand the range of perspectives in the field and to support the addiction health services research careers
of underrepresented populations.
The aims of the Pilot/Mentoring Core are to: 1) expand mentoring, networking, and educational opportunities
for a racially/ethnically diverse array of early career investigators interested in conducting research in areas
related to the theme of the Center; and 2) continue to advance the field by offering opportunities for early
career investigators to develop new, cutting-edge research ideas related to the Center theme through funded
pilot papers. The Pilot/Mentoring Core will work synergistically with the Research Core to further the combined
aims of advancing the science and developing the next generation of addiction services researchers. The
renewal Center is well poised to advance these dual goals building on successes in the current Center. Our
focus on mentoring and training will allow the Center to provide both formal and informal experiences that will
lead to the expansion of research on SUD delivery and payment systems and a broadening of the field of
researchers working on these important issues. Through the mentoring and networking opportunities created,
the Center will provide forums for the exchange of ideas, both to and from the Center, to be incorporated into
future research. These activities will serve to expand and advance the field of addiction health services
research and create strong, diverse networks of early career and senior investigators who will collaborate to
address the most vexing research questions in the field.